IRON UTILIZATION IS ASSOCIATED WITH PNEUMOCCOCAL VIRULENCE

Iron is an essential nutrient for the growth of all organisms and has very low solubility under physiological conditions. The ability to acquire iron under low-iron conditions is related to the virulence of bacterial pathogens. Mechanisms for acquisition of iron by the pneumococcus under low-iron conditions were investigated. Siderophore production was not detected by either chemical or biological methods. Its utilization of iron-containing compounds found in human hosts, e.g. transferin, hemoglobin, was tested. Both hemin and hemoglobin supported the full growth of pneumococci in a culture lacking another iron source, while human lactoferrin and transferrin failed to do so. To evaluate the significance of hemin utilization in the pathogenesis of pneumococcal infection, a mutant ST330 defective in hemin utilization was isolated by chemical mutagenesis. The virulence of the hemin utilization mutant in mice was analyzed. Mice were challenged with cells of pneumococcal type 2 and mutant ST330